SPOP drives neurodegenerative tauopathy

Abstract:
Aggregated pathological tau protein constitutes one of the diagnostic hallmarks of Alzheimer’s disease (AD) and
related disorders (ADRD). The molecular mechanisms by which pathological tau causes dysfunction and
degeneration of neurons remains incompletely understood. However, pathological tau driven neuronal
dysfunction and neurodegeneration clearly cause dementia. To investigate how pathological tau contributes to
neurodegeneration in AD and ADRD, we established a transgenic model in C. elegans for neurodegeneration
driven by human tau aggregation. In our previous work, we identified several genes that control tau toxicity in
C. elegans including sut-1, sut-2, parn-2, sut-6, aly-1, aly-2, and aly-3; all of these genes share the common
property of encoding proteins residing within nuclear speckles. Nuclear speckles are membraneless organelles
within the cell’s nucleus that function as hubs of RNA processing. Previous translational work from our
laboratory and others have shown that AD/ADRD exhibit defects in RNA processing and mislocalization of
several nuclear speckle proteins including MSUT2, PABPN1, and SRRM2. We have leveraged our C. elegans
model of tauopathy to begin to dissect the functional role of nuclear speckles in tau pathology. We found tau
mediated neuronal dysfunction and neurodegeneration can be rescued by loss of a nuclear speckle resident E3
ubiquitin ligase adaptor protein known as SPOP. We hypothesize SPOP-mediated degradation of substrate
proteins impacts the dynamics and liquid-liquid phase separation of nuclear speckles to modulate the toxicity of
pathological tau. Given the high level of conservation of the nuclear speckle proteins and RNA processing
system between mammals and C. elegans, we propose to utilize both C. elegans and mouse transgenic
tauopathy models to dissect the molecular mechanisms by which SPOP loss of function protects against tau
neurotoxicity. The Specific Aims of this project are to: 1) Define SPOP’s impact on neuronal nuclear
speckle composition and dynamics in tauopathy. 2) Identify critical non-degradative CUL3SPOP E3 ligase
ubiquitination substrate(s) participating in tauopathy. 3) Explore the role of critical CUL3SPOP substrate
proteins in both human disease and mouse models of tauopathy. By completing the proposed work, we
will develop new molecular understanding of disease mechanisms by which nuclear speckles and the SPOP
protein participate in tauopathy. This work will also provide the first translational effort at understanding whether
targeted changes in nuclear speckles can protect neurons from pathological tau in the mammalian brain.

Public health relevance
Narrative Statement: Pathological tau protein drives neurodegeneration in Alzheimer’s disease and Alzheimer’s Disease Related Dementia disorders. Aberrant tau causes neuronal dysfunction and neurodegeneration. AD and other tauopathy disorders have no effective treatment and progress to brain failure and premature death. The molecular mechanisms driving tau mediated neurodegeneration remain incompletely understood. Recent work has shown nuclear speckles participate in tauopathy related disease mechanisms, and several nuclear speckle resident proteins including SPOP control pathological tau accumulation. Completion of the proposed work will illuminate the mechanisms of tau mediated neurodegeneration setting the stage for future translational studies.